The DECREASE SSI Trial (Decolonization to Reduce After-Surgery Events of Surgical Site Infection)

Abstract
The DECREASE SSI Trial (Decolonization to Reduce After-Surgery Events of Surgical Site Infection)
Colon and small bowel surgery are high-volume, high-cost surgeries performed in over 675,000
patients in the United States each year. These surgeries carry one of the highest surgical site infection (SSI)
rates, with estimates of 11-45%, or 2- to 3-fold higher than nationally reported rates, when comprehensive
surveillance efforts are used, such as in clinical trials. Comprehensive tracking also uncovers a
disproportionate amount of post-discharge incisional SSIs. These incisional SSIs are strongly tied to patient
anxiety, stress, embarrassment, dissatisfaction, and lower quality of life scores.
Mounting evidence shows that social and economic disadvantage can adversely affect the risk of SSI,
likely due to the differential ability to protect a fresh incision from infection after hospital discharge. The
Decolonization to Reduce After-Surgery Events of Surgical Site Infection (DECREASE SSI) Trial will test the
value of adding a post-operative intervention to current pre-operative and intra-operative prevention practices.
The DECREASE SSI Trial is a multi-site pragmatic randomized controlled clinical trial comparing routine post-
discharge wound care to a post-discharge decolonization regimen of chlorhexidine bathing and nasal iodophor
to prevent SSI events in the 30 days following discharge for open colon and small bowel surgery. If successful,
this trial will provide a simple prevention measure for the 675,000 persons who undergo non-laparoscopic
surgery involving the small and large intestines each year.

Public health relevance
Project Narrative The DECREASE SSI Trial (Decolonization to Reduce After-Surgery Events of Surgical Site Infection) The DECREASE SSI Trial (Decolonization to Reduce After-Surgery Events of Surgical Site Infection) is a multi-center pragmatic randomized clinical trial to reduce post-discharge surgical site infection following open colon or small bowel surgery by comparing routine post-discharge wound care to chlorhexidine bathing plus nasal decolonization in the 30 days following discharge. This trial seeks to enhance the care of the 675,000 patients annually who undergo colon and small bowel surgery by finding simple and efficacious interventions to reduce SSI.